High-throughput injectability screening of high concentration protein formulations by microfluidic quartz resonators

The objective of this TABA proposal is to carry QATCH’s nanovisQ™ technology, which is a wide-shear-rate
range and low volume viscometer for determining developability and injectability of biopharmaceutical
formulations, from prototypes to sales. This objective is motivated by the needs of the growing protein-based
biopharmaceutical therapeutics industry (with global market size over $100 billion). Protein-based therapeutics
are administered as high concentration formulations due to the volume constraints of subcutaneous injections.
However, increased protein-protein interactions at these high concentrations can cause injectability and
manufacturability issues, which cannot be determined at early stages of drug development due to the high
sample volume requirements of conventional rheology techniques. By developing a wide shear rate range, low
volume viscometer, protein molecules can be optimized for injectability/manufacturability and candidates with
better developability can be selected for scaling-up. This TABA will address crucial gaps in QATCH’s current
expertise and team and will advance commercialization. In this TABA work, QATCH’s sales consultant will assist
QATCH for product sales through 1) developing marketing strategy, 2) preparing to execute marketing and sales,
3) executing the strategy and optimize it through feedback.

Public health relevance
Subcutaneous injections of protein-based therapeutics enable home administration and reduce the load on the healthcare facilities and healthcare costs. However, the injectability of protein-based formulations at the necessary high concentrations for injection cannot be determined at early stages of drug development due to a lack of material. Thus, protein molecules cannot be optimized or selected for injectability. Our technology addresses this by allowing the measurement of viscosity at shear-rate ranges relevant to injectability and manufacturability using very small volumes of formulations. Selling this product involves reaching out pharmaceutical companies and CDMO/CROs, developing proper messaging, and iterating through the interactions and finalizing towards cash flow. This project will help us commercialize this unique technology, which in turn will benefit drug development and consequently patient experience and adherence.